Neuromuscular adaptation to exercise in Alzheimer's Disease

PROJECT SUMMARY
During early stages of Alzheimer’s Disease (AD), skeletal muscle mass and function precipitously declines in
comparison to those who are cognitively intact, potentially due to poor neuromuscular health. Thus, bioenergetics
of peripheral tissues may have an underappreciated role in AD etiology. Exercise is an effective means to
promote mitochondrial and neuromuscular health. However, whether regular exercise has therapeutic potential
for delaying or preventing AD is an outstanding question. We present evidence of impaired skeletal muscle
AMPK-signaling response to exercise in 5xFAD mice, a model of AD and show neuromuscular dysfunction is
present at a young age before observable cognitive decline. Also, we present evidence that mitochondrial
respiration does not improve following 12 weeks exercise training in 22-week-old 5xFAD mice compared to WT.
In sum, impaired neuromuscular function may underlie a maladaptive bioenergetic response to exercise prior to
overt manifestation of AD-like pathology. There is a critical need therefore to define adaptive neuromuscular
mechanisms in relation to established neuropathological changes over the continuum of AD-like pathology to
identify novel therapeutic targets. We hypothesize impaired bioenergetics precedes manifestation of overt AD-
like neuropathology resulting in neuromuscular maladaptation to exercise training. We propose two aims: Aim
1) Determine neuromuscular adaptive response to endurance exercise training in AD mice before AD-like
pathology. We will assess mitochondrial respiration and reactive oxygen species (ROS production in intact
muscle fibers and as well as synthesis (i.e. biogenesis) and breakdown (via D2O labeling - GC/MS) of muscle
mitochondria and intact sciatic nerves in 22-week-old 5xFAD and APP/PS1 male and female mice following 12
weeks voluntary wheel running (exercise training) (1a), determine pre- and post-exercise training neve-
stimulated muscle function and sciatic nerve conductance in vivo, neuromuscular junction integrity
(histochemistry) and mitochondrial quality (1b), assess central (hippocampus) and peripheral (plasma NfL and
NMJ) neuropathology (1c), and perform untargeted metabolomics of muscle, sciatic nerve, and hippocampus
following exercise training (1d). Aim 2) Determine tissue-specific and functional roles for AMPK⍺1 in AD-like
etiology in 5xFAD mice. We will assess mitochondrial function, sciatic nerve conductance, proteostasis,
development of neuropathology, and metabolomics in both muscle, sciatic nerve, and hippocampus at 3 and 9
months of age in muscle- and motor neuron-specific AMPK⍺1 knock-out, as well as novel gain- and loss-of-
function AMPK⍺1(T172A) knock-in mice. Our findings will elucidate neuromuscular responses to exercise
training in context with AD-like neuropathology and integrated isoform-specific functional roles of AMPK⍺ in AD-
like etiology. These studies will provide mechanistic and integrated insight into novel roles for neuromuscular
dysfunction as a sentinel for AD and provide training, career development opportunities, and protected time to
establish a research program focused on mechanisms of age-related disease and healthy aging.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will advance mechanistic understanding of neuromuscular adaptation to exercise in relevant AD mouse models and the roles of a key regulator of cellular energetics in AD-like etiology, a pathology for which there are few treatment options. The project is relevant to NIA’s mission because it focuses on the molecular and physiological response of skeletal muscle mitochondria and motor nerves in the context of AD neuropathology that indicates a maladaptive bioenergetic response to exercise, which may elucidate an integrated mechanism that will take into account the system-dependent nuance of bioenergetic dysregulation in AD etiology. Training in measures of nerve activity in rodents and humans and associated professional development opportunities will complement the protected time to accomplish the research goals and establish a research program focused on mechanisms of age-related disease and healthy aging.